Novel Therapeutic for SLE

Novel Therapeutic for SLE
BioTherapeutics Inc (BTI) is a clinical-stage biopharmaceutical company focused on the discovery and
development of innovative first-in-class oral therapeutics for patients with inflammatory and autoimmune
diseases. We have developed a novel oral small molecule product candidate for the treatment of systemic lupus
erythematosus (SLE). An unmet clinical need for safer, more effective SLE drugs remains, as current therapies
have limited efficacy and significant adverse side effects.
Systemic lupus erythematosus (SLE) is an autoimmune disease that afflicts 1.5 million Americans. Lupus
nephritis (LN) is a complication of SLE that afflicts up to 60% of patients. We have identified a novel anti-
inflammatory pathway that supports immune tolerance through both regulatory CD4+ T cells (Tregs) and myeloid
cells. In a model of TLR activation that mimics the pathogenesis of SLE, the loss of this immunological target
results in a significant increase in mortality and overall disease severity. As a result, we developed a small
molecule therapeutic to activate this new target. In three mouse models of lupus, oral dosing with our novel
product candidate results in a significant decrease in proteinuria, increased Tregs, reduction of inflammatory
cells and other signs of disease. Further, our product candidate has successfully completed IND-enabling studies
with no identification of dose-limiting toxicities or target organ systems.
The Specific Aims for the SBIR Fast-Track Phase I application are to:
(1) Determine minimally effective and saturated concentrations. Mixed leukocyte reactions will be
conducted to estimate the amount of drug needed to elicit a response from immune cells.
Transition Milestones are: i) increase in abundance in Tregs at one or more dose levels; ii) decrease in MCP1;
and iii) statistical differences in tested blood markers at one or more dose levels.
The Specific Aims for the SBIR Fast-Track Phase II application are to:
(2) Conduct chronic toxicity studies. We will conduct 6-month rat and 9-month dog chronic repeat dose
toxicity studies at 0, 250, 500 and 1000 mg/kg.
(3) Evaluate combinatorial therapeutic efficacy with current standard of care drugs in mouse models
of SLE. We will use NZB/W F1 and MRL/lpr models of SLE to determine if mechanistic synergisms exist
with current standard of care.
Expected successful outcomes will be: i) NOAEL ≥ 1000 mg/kg in all toxicology studies; ii) equal or greater
efficacy relative to current SLE drugs; and ii) absence of destructive effects.
The long-term goal of this SBIR application is to develop a novel lead compound as a safer, more effective first-
in-class oral therapeutic for SLE through translational, toxicological and preclinical studies. This research will
address an unmet clinical need for a market exceeding $2.6 billion and growing 11% annually.

Public health relevance
Public Health Relevance Systemic lupus erythematosus (SLE) is a highly heterogeneous disease capable of manifesting numerous pathologies including kidney failure, cardiovascular disease, and chronic pain in over 5 million individuals worldwide with lupus nephritis (LN) occurring in up to 60% of patients. Current therapeutics are ineffective in SLE due to an inability to intercept the disease at multiple levels which has culminated in only a single new drug approval in over 50 years for SLE. This SBIR application will develop a novel first-in-class and best-in-class therapeutic for SLE.